NUTROPIN TO IMPROVE WELL BEING IN GROWTH HORMONE DEFICIENT ADULTS

The purpose of this phase II study is to document that growth hormone treatment in growth hormone deficient adults results in a durable improvement in body composition and to assess its effect on metabolism and overall sense of well being.